iPSC Derived Cardiac Microchambers for Embryonic Drug Screening

? DESCRIPTION: In this application, we aim to establish an in vitro model to recapitulate early heart development for safety assessment of specific drugs commonly administrated during pregnancy. In aim 1, we will test our hypothesis that cardiac tissue morphogenesis can be modeled in vitro by micro patterning and differentiation of human induced pluripotent stem cells (hiPSCs). We will establish and optimize our in vitro early developing heart model by obtaining a full spectrum of 3D cardiac micro tissues generated from hiPSC patterns with different geometries. In aim 2, we will validate our model by the drugs listed in pregnancy risk categories A and X as negative and positive controls, so we will be able to predict the drug toxicity from categories B-D on early heart development.

Public health relevance
PUBLIC HEALTH RELEVANCE: Because pregnant women are normally excluded from clinical trials, prescription medicines are rarely studied in pregnant populations prior to commercialization. Currently, rodent-based in vitro developmental toxicity assays have limited relevance to human physiology due to specie barrier, whereas no human in vitro model has been established to recapitulate in vivo organogenesis for safe drug screening in a high-throughput manner. In this application, we will use human induced pluripotent stem cells to establish an in vitro model to recapitulate early heart development, which would be a pioneering breakthrough in drug discovery, regulation and prescription for safe pregnancy and fetus development.